Identification of isoform-selective ALDH inhibitors

During this period, the project team has performed high-throughput screening of a small set of NCATS libraries using ALDH1A2, ALDH1A3, ALDH2 and ALDH3A1 biochemical assays. The hit compounds identified have been validated in follow-up screens as well as in cell-based activity and target engagement assays. The assays were utilized to determine compound activity as well as selectivity against isoforms. The dataset generated was used for in silico screening covering a larger chemical space to uncover additional hits. The platform established has identified chemotypes for future development.